Enhancing hair cell regeneration in the mature cochlea: Modulating Sox gene control of supporting cell identity

Project Summary/Abstract
The goal of this project is to investigate whether the loss of key supporting cell fate genes will enhance the
reprogramming and regeneration of cochlear cells into hair cells as a strategy for hearing restoration. We have
found that supporting cells of the mature cochlea can be reprogrammed into hair cell-like cells following
combined damage AND reprogramming with Atoh1+Gfi1+Pou4f3. We have also found that non-sensory cells
of the inner and outer sulcus can be reprogrammed with Atoh1+Gfi1+Pou4f3 and provide a second potential
population of cells for hearing restoration. Here, we are targeting two Sox-family genes that regulate hair cell
fate but are expressed in supporting cells and other non-sensory cells in the mature cochlea.
Sox-family members Sox2 and Sox10 are both linked to hair cell fate decisions as they each produce ectopic
hair cells when one allele is lost. Supporting cells nearest to the inner hair cells appear to be particularly
susceptible to the combined loss of both Sox2 AND Sox10 in the production of ectopic inner hair cells.
Moreover, preliminary data suggests that reprogrammed hair cell-like cells do not turn off Sox2 or Sox10
possibly limiting their complete fate conversion. Remarkably, the loss of one allele of Sox2 increases the
number of regenerated hair cells suggesting that it is preventing hair cell fate in these cells.
Here, we hypothesize that supporting cell network genes, Sox2 and Sox10, are restricting the cell’s ability to
turn into a hair cell following reprograming. To test this hypothesis, we will use genetically modified mouse
models to reprogram and regenerate cochlear cells into hair cell-like cells. In addition to reprogramming we
will: i) completely delete Sox2 from cochlear supporting cells in the organ of Corti, ii) delete one copy of Sox10
from non-sensory cells of the inner and outer sulcus, and iii) delete one copy of Sox2 PLUS one copy of Sox10
from supporting cells in the organ of Corti. Following each of these genetic manipulations, we will investigate
whether the number or the maturity of hair cell-like cells has improved. We anticipate that our studies will
reveal a unique role for supporting cell network genes as a target for hearing restoration therapies.

Public health relevance
Project Narrative Acquired hearing loss is prevalent throughout the world and accounts for, not only a significant cost to the lives of those living with it, but it also accounts for a significant monetary cost to individuals and societies. Hearing deficits can result from the loss of cochlear hair cells, which do not naturally regenerate in humans and other mammals leading to permanent impairment. Therefore, strategies to reprogram neighboring cells into hair cells will provide therapeutic targets for hearing restoration.